NGF recruits nerve fibers to reprogram an immunosuppressive microenvironment in melanoma

Nerve infiltration has been implicated in the formation and progression of several solid tumor types
including prostate, gastric, and pancreatic cancers. However, despite its neural origin, melanoma
innervation has not been previously reported. In our preliminary studies, we discovered that melanoma
tumor tissues from patient samples and mouse models are highly innervated. This innervation is
dependent on tumor cell expression of nerve growth factor (NGF), as targeted NGF depletion eliminates
intratumoral nerve fibers. Importantly, melanoma denervation via NGF knockdown or chemical
sympathectomy dramatically reduces tumor burdens by remodeling the tumor microenvironment (TME).
This TME reprogramming is associated with increased cytokine and chemokine expression, CD103+ DC
activation, and CD8+ T cell recruitment, suggesting that NGF or nerve-derived neurotransmitters support
tumor growth by suppressing antitumor immunity. Importantly, we confirmed this inverse correlation
between tumor innervation and inflammation using clinical samples: melanomas expressing low levels of
NGF are immunologically hot and associated with improved patient survival. These findings inspire our
central hypothesis that NGF-mediated innervation of the tumor microenvironment can be exploited
pharmacologically to reverse immunosuppression. In this study, we will test this hypothesis with the
following three aims: Aim 1 will dissect molecular mechanisms of NGF-mediated remodeling of the
intratumor immune microenvironment. Aim 2 will dissect molecular mechanisms by which NGF regulates
T cell activation. Aim 3 will determine the pre-clinical efficacy of a therapeutic strategy combining NGF
axis inhibition and immune checkpoint blockade against melanoma. Findings from the proposed studies
will lay the foundation upon which potential combinational therapies can be developed to combat this
disease.

Public health relevance
Project Narrative Cancer immunotherapy has shown great promise in combatting cancer, but interactions between cancer cells and the immune system or anti-tumor immune response within the tumor microenvironment remain to be explored to increase the potential of this approach as a major arsenal for cancer treatment.